Improving treatment of lactation mastitis: leveraging claims data to fill evidence gaps

SUMMARY
Lactation mastitis is an extremely painful and debilitating condition that affects 10-25% of breastfeeding people
and can progress to breast abscess or septic fever. This significant disease burden occurs mostly during the first
six months when birthing people are still in recovery from pregnancy and childbirth. The objective of the proposed
study is to compare classes of antibiotics on first-line treatment failure and document disparities in severity at
presentation and antibiotic prescription rates by race/ethnicity. Our central hypotheses are that some treatments
are more effective than others for avoiding treatment failure and that there are measurable disparities in severity
at presentation and treatments prescribed by race/ethnicity. We will construct a cohort of >5,000 diagnosed
mastitis cases utilizing a nationwide healthcare claims dataset and conduct rigorous analyses to explore these
hypotheses. Our team is uniquely poised to answer these critical research questions and includes an infectious
disease epidemiologist, a lactation clinician who co-authored the current mastitis treatment guidelines, and an
expert in using claims data to asses downstream impacts of medication use. Specifically, we aim to: (1) Compare
the effectiveness of classes of antibiotics (e.g., first and second generation penicillins, cephalosporins,
lincosamides, sulfonamides) prescribed for lactation mastitis on first-line treatment failure, abscess, and hospital
admission. We hypothesize that given community and hospital transmission of MRSA, short-course penicillins
will have the highest rate of first-line treatment failure. (2) Describe disparities by race/ethnicity in the severity of
mastitis at presentation and the antibiotic prescription patterns after mastitis diagnosis. We hypothesize that
given barriers to antenatal care and implicit provider bias, Black and Latina/e/x breastfeeding people will present
with more severe cases of mastitis and are prescribed antibiotics less frequently after diagnosis in comparison
with white breastfeeding people. The proposed study will make significant and novel contributions toward
understanding current patterns in antibiotic prescriptions for mastitis treatment and the relative effectiveness of
current antibiotic treatments. The formation of a mastitis diagnosis cohort using the Optum dataset will provide
a platform to assess a number of other important factors such as local antibiotic resistance patterns and to
assess the impact of changing policies (both mastitis treatment and antibiotic stewardship policies) on successful
treatment. These results will also provide information on the most effective treatments to assess in future
randomized trials. Innovative aspects of our proposal include: (1) high-quality observational studies that advance
our understanding and can guide the design of future randomized trials, (2) assessment of treatment disparities
by race/ethnicity which is critical for responding to clinical and social realities, and (3) large data that covers the
US geographically.

Public health relevance
PROJECT NARRATIVE In this study, we will investigate whether the type of antibiotic prescribed gives better outcomes. As well, we will make significant contributions towards understanding current racial disparities in practices of prescribing antibiotics to treat breastfeeding-related mastitis. These critical research areas need to be addressed to give clinicians and patients the information about which treatments work best and identify areas where randomized trials are needed.